CNS Effects of Alcohol: Cellular Neurobiology

Changes to proposed revised activities are in red
Revised Abstract Overall
The Scripps Research Institute-Alcohol Research Center (TSRI-ARC) will focus on the cellular and molecular mechanisms that modulate top-down medial prefrontal control of the central amygdala and underlying stress induced vulnerability to relapse and excessive drinking during protracted abstinence. Our approach consists of coordinated interdisciplinary molecular, neuroproteomic, cellular, neurocircuitry, connectomic, neuropharmacological, and behavioral methods. Specific hypotheses are: (1) Protracted abstinence involves increased vulnerability to stress-induced relapse via changes in modulatory control circuitry from the infralimbic cortex to the central nucleus of the amygdala. (2) Modulatory control changes are a function of altered
glutamatergic and γ-aminobutyric acid synaptic transmission, due to actions of stress-related molecules (including hypocretin, corticotropin-releasing factor, dynorphin, and nociceptin) and astrocytic dysfunction. (3) These neurocircuitry changes are associated with altered connectivity and decreased modularity of brain networks, leading to increased vulnerability to stress-induced relapse. (4) Novel translationally relevant ligands of neurobiological targets identified by TSRI-ARC will attenuate the reinstatement of stress-induced alcohol seeking, excessive drinking, and stress-related behaviors in animal models. Our Center-wide aims will be met by 5 Research Components (Functional Connectomics, Neuropharmacology, Molecular, Neurophysiology, and
Neurocircuitry), and 4 Cores (Administrative, Dissemination, Animal Models, and Neuroproteomics). The Administrative Core is organized to optimize Center-wide functioning, utilization of Core resources, and research collaborations in the Center-at-Large. TSRI-ARC is structured to inform about the impact of alcohol on health outcomes on all Americans; to promote the dissemination of our results to the general community; to provide accessible education, training and career development at all levels of the Center. TSRI-ARC rapidly disseminates its discoveries to scientific, healthcare and lay stakeholders, and engages young people and recruit students based on merit without any discrimination for internships in TSRI-ARC laboratories to learn about alcohol and careers in alcohol research. Center-wide Specific Aims are: (1) To characterize the cellular and molecular mechanisms that modulate top-down medial prefrontal control of the central amygdala and underlie stress-induced vulnerability to relapse and excessive drinking during protracted abstinence. (2) To understand how reversal of the cellular and molecular stress mechanisms that impair modulatory control systems can prevent stress-induced relapse and excessive drinking during protracted abstinence. (3) To evaluate the efficacy of neuropharmacological targets identified by TSRIARC for reversing dysregulated connectivity within and between brain stress systems and modulatory control circuits in protracted abstinence. The ultimate goal of TSRI-ARC is to positively influence public health by generating data relevant to the identification of neurobiological mechanisms mediating alcohol use disorder (AUD), and guide the translation of our basic research findings toward clinical applications to help in prevention, diagnosis, and treatment of individuals with AUD.

Public health relevance
Narrative It is well established that most individuals with alcohol use disorder (AUD) can briefly quit drinking, but a significant challenge is to not relapse to excessive drinking following a period of abstinence. The TSRI-ARC renewal addresses key gaps in our understanding of AUD, in that it focuses on the less well-understood persisting heightened neurobiological stress responses and impaired cortical control that may drive drinking relapse. The overall goal of TSRI-ARC is to identify fundamental neurobiological mechanisms mediating AUD, and guide the translation of our basic research findings toward helping individuals recover from AUD.